Molecular mediators of disparate outcomes experienced by patients of African ancestry with lung cancer

PROJECT SUMMARY
Lung cancer causes 1 in 5 deaths from cancer in the United States – more than any other malignancy. The
burden of lung cancer deaths disproportionately impacts Black/African Americans for reasons that cannot be
completely explained by social elements of health. Moreover, African Americans are chronically
underrepresented in clinical trials and large-scale molecular profiling studies, suggesting potential unidentified
mechanisms of therapeutic resistance. In preliminary studies, we determined ancestral composition of tumor cell
lines and patient tumors using genomic profiling, and we found numerous molecular alterations associated with
genomic ancestry. Notably, both cell lines and primary tumors from patients of European ancestry exhibited
higher EGFR phosphorylation than those from patients of African ancestry. EGFR inhibitors are first-line
treatments for patients with EGFR mutant lung cancer, despite minimal or even zero enrollment of African
Americans in underlying clinical trials. EGFR phosphorylation remained significantly different when analyzing
only EGFR mutant tumors. We detected no difference in EGFR mutation frequency based on patient ancestry.
However, EGFR-mutant tumors from patients of African ancestry harbored a higher rate of additional mutations
in oncogenes that are typically mutually exclusive with EGFR mutations, suggesting that EGFR mutation may
be an insufficient oncogenic driver in this population. Critically, these observed molecular differences
corresponded with a lack of EGFR inhibitor toxicity in cell lines from patients of African ancestry. In contrast,
tumors/cell lines from patients of African ancestry exhibited elevated activation of DNA damage response
pathways and heightened sensitivity to multiple DNA damage response inhibitors. This study will evaluate the
hypothesis that heritable, ancestry-associated molecular features may contribute to disparate outcomes by
influencing response to specific therapeutic modalities. We will evaluate this hypothesis by completing the
following Specific Aims:
Aim 1 will determine how EGFR signaling differs based on patient genetic ancestry.
Aim 2 will quantify the interplay between EGFR activation, co-mutations, ancestry, and treatment outcomes.
Aim 3 will identify novel therapeutic strategies that are more effective for patients of African ancestry.
Together, these studies will provide critical insight into mechanisms underlying disparities in lung cancer
outcomes and facilitate the development of therapeutic regimens to benefit patients with lung cancer.

Public health relevance
NARRATIVE Lung cancer is the leading cause of cancer deaths in the United States and disproportionately impacts African Americans through mechanisms that cannot be entirely explained by social elements of health. We identified ancestry-associated molecular features associated with resistance to common lung cancer therapies. The goal of this study is to mechanistically understand how these molecular alterations influence therapy resistance and to identify effective alternative regimens to improve care for all patients with lung cancer.